Environmental Agents as Modulators of Disease Processes

Abstract: The overarching goals of the Rochester Environmental Health Sciences Center (EHSC) are to prevent
disease and improve health by advancing innovative and impactful translational environmental health
research, engaging communities to address environmental health issues, and enhancing career
development of talented environmental health investigators. More specifically, the goals of the Center are to:
(1) enrich the ability to hypothesize and implement cutting-edge translational environmental health research
using modern approaches that also move knowledge into action; (2) advance science by stimulating the
prediction and prevention of detrimental exposures on health across the lifespan by developing and using
the best available tools and approaches, and integrating new information to understand cumulative risks;
(3) promote career development of the next generation of environmental health investigators in a diverse,
inclusive, supportive, and collaborative environment; (4) foster interactions of Center members and
community partners to cultivate new ideas and respond to issues of concern at the local, national, and
international level; and (5) support existing and build new institutional and inter-institutionalpartnerships. The
Rochester EHSC achieves these goals by providing a framework that is anchored in our overall mission to
improve public health through the generation of fundamental knowledge and elaboration of mechanisms by
which chemical exposures, alone or through interaction with other modifying factors, contribute to cumulative
health risk across the life span. A key strength of the Center is that activities are not siloed within the study
of a specific organ system or a single disease. As such, the central theme that integrates EHSC research and
community engagement programs is the desire to understand how exposures and interactions of
environmental factors affect health and disease across the lifespan. This theme weaves together and
synergizes Center member efforts, such that the totality of our impact is greater than each part would achieve
on its own. Further supporting the Center is a strong tradition of emphasizing and integrating basic
mechanistic research in model systems with clinical and epidemiological approaches, which catalyzes
multidirectional transformation of new information into actions. The Center also sustains strong community
partnerships that develop, advise, and also learn from new methods and engage diverse communities in our
region and across the nation. Unique and expanded strengths of our Center combined with emerging new areas
underlie proposed Center activities, programs, and use of resources, and provide the foundation for future
success. Further supporting our success is the broad-based scientific diversity of our faculty, which ideally
positions us to apply integrative and innovative strategies to address critical questions in environmental health
sciences.

Public health relevance
Project Narrative The mission of the Rochester EHSC is to improve health through the creation of knowledge and discovery of mechanisms by which environmental exposures, singly and in combination, contribute to health risk across the life span, and translating findings into strategies to mitigate risks and improve human health. This mission is achieved by supporting scientific research and translating this research through community engagement and education. Thus, the EHSC provides the framework for the generation of novel research discoveries and their conversion into effective resources for scientists, public health officials, medical professionals, and communities.